Deep Learning of Renal Scans and Kidney Ultrasounds in Children with Antenatal Hydronephrosis

Project Summary/Abstract
The candidate for this K08 Career Development Award aims to become a leader and innovator in applying
bioinformatics and computational research to the study of pediatric urologic diseases with the goal of improving
patient outcomes. Antenatal hydronephrosis (ANH) is one of the most common anomalies identified on prenatal
ultrasound, found in up to 4.5% of all pregnancies. Up to 30% of ANH is secondary to urinary tract obstruction,
most often unilateral ureteropelvic junction obstruction (UPJO). Early identification of infants with obstruction is
critical, as obstructive uropathy exposes the kidney parenchyma to high pressures which causes progressive
loss of kidney function. Patients with ANH are surveilled with kidney ultrasounds; a mercaptoacetyltriglycerine
(MAG3) diuretic renal scan is performed to evaluate for UPJO when there is high suspicion on ultrasound.
However, current evidence has established a wide range of “indeterminate” drainage times (approximately 10-
40 minutes), for patients with ANH and suspected UPJO, making interpretation and application of renal scan
findings difficult. The resulting high inter-observer variability among pediatric urologists, can result in
unnecessary surgery in infants without obstruction or delay treatment for those with obstruction. The proposed
project aims to utilize machine learning to derive clinically useful anatomic signatures of the kidney from MAG3
renal scans and kidney ultrasound imaging data and diagnose UPJO with greater accuracy than the current
standard of care. In an initial cohort of patients, his preliminary model built using only features from MAG3 renal
scans identified clinically significant obstruction in patients with suspected UPJO. In Aim 1 of the proposed study,
he will develop a multimodality deep learning model combining features from both MAG3 renal scans and kidney
ultrasounds to predict clinically significant obstruction in children with suspected UPJO. He will compare the
performance of the multimodality model to his prior model built using only MAG3 renal scans. In Aim 2, he will
compare the best performing model from Aim 1 to that of an expert panel of pediatric urologists. Finally, in Aim
3 he will provide his best performing model’s output to physicians during their clinical decision-making process
and determine if the model improves physician confidence and accuracy when predicting clinically significant
obstruction in patients with suspected UPJO. The result of this work will be a model that can augment a pediatric
urologist’s surgical decision making for patients with UPJO. The proposed project will provide the candidate the
opportunity to develop skills in implementation science methodology, advanced machine learning methods,
advanced statistics, trial design and execution, and development as a leader. The candidate’s primary mentor,
Chris Flask, PhD, is an international expert in quantitative imaging analysis techniques and has an outstanding
track-record of mentorship. The training the candidate receives during the award coupled with his advanced
research degree, exceptional mentorship, robust institutional research infrastructure, and experience in machine
learning research will position him to achieve scientific independence and write an R01 during the K08 award.

Public health relevance
PROJECT NARRATIVE: Obstruction of the flow of urine from the kidney to the urinary bladder can cause increased back pressure on the kidney that over time can injure the kidney. Currently available imaging techniques are not able to reliably identify children who are actively experiencing an obstruction. Machine learning can potentially better determine which patients are experiencing obstruction by identifying features from imaging studies that are not apparent to human reviewers.